OpenMM: Scalable biomolecular modeling, simulation, and machine learning

PROJECT SUMMARY / ABSTRACT
OpenMM is a widely used toolkit for molecular simulation and modeling (>1.5 million downloads, >2400
citations, >1M deployed instances). Its Python API makes it widely popular as both an application (for
modelers) and a library (for developers), while its C/C++/Fortran bindings enable major legacy
simulation packages to use OpenMM to provide high performance on modern hardware. OpenMM has
been used for probing biological questions that leverage the $20B global investment in structural data
from the PDB at multiple scales, from detailed studies of single disease proteins to superfamily-wide
modeling studies and large-scale drug development efforts in industry and academia. In addition to
having a very large user base, OpenMM is an essential component of many high-impact projects, such
as AlphaFold2 and Folding@home.
The first period of this grant enabled OpenMM to transition toward a community governance and
sustainable development model, build a highly popular quantum chemical dataset that has enabled the
community to build accurate machine learning (ML) potentials that deliver QM-level accuracy, and
integrate support for fast GPU-accelerated protein:ligand simulations that make use of these ML
potentials but can still achieve fast near-molecular mechanics (MM) speeds. In the next period, we
propose to build on these successes to generate much more extensive datasets, integrate multiple
other ML potentials to greatly expand the application domain they can be used for, and further
accelerate and parallelize these simulations. We also aim to integrate key methodological
improvements to improve accuracy for drug discovery applications. To be maximally responsive to the
continually growing needs of the large OpenMM user community, we also aim to onboard a new
developer focused on implementing community-requested features. To ensure OpenMM remains
highly relevant to the modern machine learning revolution, we will continue to expand the ability of
OpenMM to interoperate with modern ML frameworks such as TensorFlow, PyTorch, and JAX.

Public health relevance
NARRATIVE Biomolecular modeling and simulation is a key technology for leveraging the $20B global investment in biomolecular structure data in the protein databank to understand the basic molecular mechanisms underlying biology and disease and the development of new therapies. In this proposal, we aim to expand the development of OpenMM, a free and open source biomolecular modeling and simulation package that can exploit a wide range of consumer-grade and high-end graphics processing units (GPUs) to enable researchers and applications built on OpenMM to achieve high performance with extreme ﬂexibility. A key aspect of this proposal is to accelerate research in the emerging ﬁeld of biomolecular machine learning by tightly integrating OpenMM with modern machine learning frameworks, enabling researchers to build, use, and deploy machine learning potentials, collective variables, and integrators to advance the state of biomolecular modeling.